Automated Long-Term Oxygen Therapy Control System

Project Summary/Abstract
This proposed project relates to the development and evaluation of a novel closed-loop long-term oxygen
therapy control system that includes an innovative smartphone-based companion software application. We
hypothesize that such a system will optimize oxygen delivery in mobile patients, minimize hypoxemia and air
hunger during physical exertion, avoid hyperoxia and improve patient health-related quality of life. More than
1.5 million Americans are currently receiving long-term oxygen therapy. Drawbacks to long-term oxygen
therapy include significant limitations to patient physical activity, a heightening of social isolation and decline in
emotional well-being. Improved mobile technology is needed to address these drawbacks and improve patient
outcomes. A production prototype system will be designed, built, and evaluated.

Public health relevance
Project Narrative Long-term oxygen therapy is widely prescribed for people with chronic lung or heart diseases. In the U.S., there are 1.5 million people on long-term oxygen therapy. An improved oxygen control system that optimizes oxygen delivery, particularly when used outside the home when patients are physically active, is needed and would improve the patient quality of life.